Supplement to Promote Diversity: Characterizing Low Alcohol Sensitivity in Laboratory and Real-World Contexts

PROJECT SUMMARY Not applicable for this submission. The summary has not changed from Parent R01.

Public health relevance
PROJECT NARRATIVE Not applicable for this submission. The narrative has not changed from parent R01.